Project 3

PROJECT SUMMARY
Although up to 80% of mental health services for youth are currently provided in schools, few students receive
evidence-based practices (EBPs). Even when organizational supports are in place, implementation ultimately
rests with providers' motivation for change. Individual provider behavior change is critical to achieve high-quality
implementation and positive outcomes for youth. For the public to benefit from the decades of research invested
in EBP development, implementation strategies that target provider motivation are needed.
Beliefs and Attitudes for Successful Implementation in Schools (BASIS) is a four-hour, facilitated, group-
based, blended implementation strategy designed to augment standard EBP training and consultation
procedures by improving provider engagement and motivation. Using strategic education, motivational
interviewing, and social influence strategies, BASIS aims to impact key, theoretically-derived, individual-level
mechanisms associated with clinician behavior change—attitudes, social norms, and perceived behavioral
control—to improve treatment quality (i.e., fidelity), and youth outcomes. In two previous trials, BASIS delivered
in-person demonstrated evidence of feasibility, appropriateness, and efficacy, but it could be optimized for
greater scalability and efficiency, so that it can be used widely to positively impact clinicians' engagement.
Consistent with the goals of the IMPACT Center, the current project will focus on increasing BASIS scalability
by (1) optimizing BASIS to include only the most essential components for activating its target mechanisms and
(2) adapting its delivery to a web-enabled digital platform. We will build causal pathways using theory and
stakeholder input (practice community, youth), enroll representative end users, and use rapid analogue methods
(RAM) to efficiently identify and test BASIS components, as well as prioritize them for digital deployment.
Aims of this study are to apply IMPACT Center methods in order to: (1) Identify and prioritize BASIS
components via causal pathway diagramming; (2) Conduct tests of prioritized BASIS components using RAM to
inform the development of an optimized eHealth adaptation of BASIS (eBASIS); and (3) Test the impact of
eBASIS on EBP fidelity and youth outcomes in a randomized controlled trial (RCT). Key organizational factors
(e.g., leadership, implementation climate, school characteristics) will be measured as covariates during the RCT.
Promising findings would support an R01 application for a confirmatory trial evaluating the impact of eBASIS on
fidelity and youth outcomes. We anticipate that the eBASIS implementation strategy will be readily scalable and
could enhance the impact of EBP integration efforts to improve treatment quality and outcomes for youth in the
education sector and other low-resource community settings.